BLRD Research Career Scientist Award Application for Howard Becker, PhD

Alcohol use disorder (AUD) is a chronic relapsing disease that constitutes a major health problem for Veterans
and society in general. Likewise, stress-related disorders, such as post-traumatic stress disorder (PTSD) are
highly debilitating and present with especially high prevalence in Veterans as well. Stress is known to play a
significant role in triggering relapse and promoting excessive, harmful levels of alcohol use. This is of particular
concern because the frequent co-occurrence of stress and alcohol related disorders is associated with more
severe clinical symptoms and medical complications compared to either disorder alone. The prevalence of PTSD
and AUD comorbidity is especially high in Veterans, with prevalence rates reported in the 55-75% range. Given
the high prevalence of PTSD-AUD comorbidity in Veterans, it is not surprising that the Department of Veterans
Affairs has highlighted this as a special and high priority research area. Thus, the need to better understand
underlying mechanisms of stress-alcohol interactions is paramount to developing more effective treatment
strategies to address this significant medical problem.
The overall focus of Dr. Becker’s Alcohol Research Program at the Charleston RHJ VA Medical Center is aimed
at elucidating neural mechanisms and brain circuits underlying the ability of stress and chronic alcohol (ethanol)
exposure to promote/mediate excessive levels of drinking. The Becker research lab has played a leading role in
developing novel, clinically relevant animal models that enable multidisciplinary analyses of the complex and
dynamic nature of stress-alcohol interactions. The research program employs a comprehensive and integrative
approach, utilizing innovative neurobehavioral, neurochemical, and molecular biology techniques to address
research questions of particular relevance to the overall VA health care mission.
One line of research focuses on the role of brain-derived neurotrophic factor (BDNF) in stress-enhanced alcohol
drinking. We showed that chronic alcohol-induced excessive drinking is associated with a deficit in cortical BDNF
expression, an effect exacerbated by stress. Increasing cortical BDNF activity reversed these effects and since
exercise is known to elevate BDNF levels in brain, we are currently employing molecular and pharmacological
approaches to examine mechanisms by which exercise increases BDNF signaling in the brain and thereby
reversing the ability of stress to enhance alcohol drinking. Another set of studies utilizes molecular,
chemogenetic, and pharmacological approaches to examine mechanisms and circuitry underlying adaptations
in pro-stress (dynorphin) and anti-stress (oxytocin) neuropeptides that contribute to stress-enhanced drinking
and relapse. Using a novel model of PTSD-AUD comorbidity that demonstrates long-lasting sensitization of
stress-induced alcohol relapse/drinking in mice with a history of chronic stress exposure, selective targeting of
subpopulations of neurons and specific brain pathways has advanced new insights about mechanisms
underlying excessive drinking, increased relapse vulnerability, and impaired behavioral/cognitive flexibility
associated with stress and chronic alcohol exposure. Another long-standing area of focus in the Becker lab has
been the development of clinically relevant animal models that facilitate discovery of new and novel treatment
targets as well as utilizing these models to evaluate potential therapeutic strategies for mitigating maladaptive
changes that engender harmful alcohol drinking and the capacity for stress to exacerbate the problem.
Collectively, Dr. Becker’s Alcohol Research Program embraces cutting-edge, translational research efforts
dedicated to developing more effective treatment strategies for stress and alcohol related disorders – a
significant medical problem for Veterans. As such, his research, administrative, and educational leadership role
as SRCS continues to significantly impact and contribute to the overall VA patient care mission.

Public health relevance
Alcohol use disorder (AUD) and stress-related disorders such as post-traumatic stress disorder (PTSD) constitute a significant health concern for our Veterans. Given that the prevalence of AUD and PTSD comorbidity is especially high in Veterans, the need to better understand how stress interacts with alcohol is critical for developing more effective treatments for this significant health problem. The Becker research program utilizes novel models involving stress and alcohol exposure, along with cutting-edge experimental tools to probe neural mechanisms and brain circuits underlying enhanced alcohol drinking, relapse vulnerability, and cognitive impairments associated with stress and chronic alcohol exposure. The ultimate goal is to provide new insights for developing novel therapeutic interventions that will aid in treatment for individuals suffering from stress and alcohol related disorders - an especially important and clinically relevant problem for our Veteran patients.